The National Diabetes Prevention Program in Rural Communities

PROJECT SUMMARY
Diabetes disproportionately impacts the 60 million individuals living in rural areas where the prevalence of Type
2 diabetes (T2D) is ~17% higher than in urban areas. The Centers for Disease Control and Prevention’s (CDC)
National Diabetes Prevention Program (NDPP) which includes a minimum of 16 weekly core sessions over 6
mos. and 6 monthly maintenance sessions provides the framework for the prevention of T2D in the U.S.
NDPP recognized programs are available in ~28% of U.S. counties; however, access to at least 1 NDPP
recognized program is significantly lower in rural (2.6%) compared with urban areas (11.1%). The Cooperative
State Research, Education and Extension Service, a partnership between the U.S Department of Agriculture,
land-grant universities and county governments represents a potentially effective but underutilized site for
delivery of NDPP to rural residents. However, evidence to support the effectiveness of the NDPP lifestyle
intervention in rural adults with prediabetes defined by CDC criteria, with the intervention delivered by
Cooperative Extension staff who have completed CDC approved training and using CDC recommendations for
both program curriculum and meeting schedule is unavailable. Distance learning, e.g., group video using
Zoom®, for delivery of NDPP is currently approved for CDC recognition. Remote delivery platforms provide a
potentially cost-effective strategy for improving participation and retention, which are both important predictors
of weight loss and reduced diabetes incidence in NDPP. The proposed 12-mo. Type II hybrid effectiveness-
implementation trial will compare the effectiveness of the NDPP protocol delivered via distance learning by
agents associated with Kansas State Research and Extension (KSRE) serving as a lifestyle coach (GV-NDPP)
vs. a self-directed control arm (SD-NDPP) which will receive the NDPP curriculum on the same schedule used
for the GV-NDPP arm delivered to individual participants via an iPad® with available lifestyle coach support.
Ten KSRE local units/districts serving rural Kansas counties will be allocated to either active (n=5) or passive
recruitment (n=5). Active recruitment will form collaborations with rural health clinics to identify potential
participants using clinic electronic health records. Passive recruitment will use traditional recruitment
techniques, e.g., flyers, email list serves, media advertising etc. Each of the 10 sites will recruit 16 adults with
prediabetes defined using current NDPP criteria living in the county served by KSRE (n=160) who will be
randomized (1:1) to one of the 2 intervention arms. Aim 1 will compare weight change between the GV-NDPP
and SD-NDPP arms across 12 mos. Secondarily, we will compare the proportion of participants meeting CDC
weight loss (≥5%) and physical activity goals (≥150 min./wk.), and changes in hemoglobin A1c across 12 mos.
between intervention arms. Aim 2 will compare the effectiveness of passive and active recruitment. Aim 3 will
compare the cost and cost effectiveness of delivery (GV-NDPP vs. SD-NDPP) and recruitment (passive vs.
active) methods.

Public health relevance
Project Narrative This project will evaluate the effectiveness of The National Diabetes Prevention Program (NDPP) when delivered by U.S. Cooperative Extension staff to adults with prediabetes in rural areas and compare active and passive strategies for participant recruitment. If this approach is effective, delivery of the NDPP through Cooperative Extension has the potential to improve access and sustainability of the NDPP for the prevention of Type 2 diabetes in underserved rural areas across the U.S.